CORE CATS-SERRS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Development of new Optical technologies for Mechano Biology and Skin Imaging. A Spatial Light Modulator will be added to the system for Mechano Biology studies. A Raman Microspectroscopy technique will be also incorporated to the system for taking a finger print signature of chemical components of the target.